Generality-Oriented Development of Novel Methods for the Synthesis of Enantioenriched Sulfondiimines Using Data Science

PROJECT SUMMARY/ABSTRACT
Sulfur is an important heteroatom in pharmaceuticals, with 30% of the top-grossing small-
molecule drugs in 2022 containing sulfur. Highly oxidized sulfur functional groups, such as
sulfonamides, are particularly common. Sulfondiimines are a type of high oxidation state sulfur
compound that can be chiral, which is an important property in drug molecules. However,
synthesis of sulfondiimines, especially with high selectivity for one enantiomer, can be challenging
and exhibit poor safety profiles. It is clear that the development of improved methods for
sulfondiimine synthesis would be beneficial. One approach to method development is using data
science, which can expedite the optimization process by allowing for in silico screening. Data
science models have the potential to give insight into mechanistic details of reactions when
applied in tandem with computational chemistry tools and careful data generation. A challenge
within this method development is to identify general conditions that work for many compounds
of a general synthetic goal. One approach to develop a generalizable reaction is by optimizing
conditions around several compounds rather than a single model substrate. Thus, the primary
aim of this proposal is to develop generalizable novel synthetic methods for sulfondiimines using
data science.
This goal will be achieved by applying a generality-oriented, data science-driven reaction
development approach to two specific aims: (1) a desymmetrization of sulfondiimines and (2)
selective addition to fluoro-λ6-sulfanenitriles. The separate synthetic strategies could allow for
access to a broader range of sulfondiimines, as each may exhibit different reactivity profiles for
various compounds. These methods will be showcased through broad substrate scopes featuring
syntheses of sulfondiimine analogues for known sulfonamide-containing cancer drugs. A long-
term application of this proposal is the synthesis of a library of sulfondiimine analogues of known
drug targets for analysis as potential therapeutics.

Public health relevance
PROJECT NARRATIVE The development of novel and improved methods to synthesize sulfondiimines will expand access to potentially therapeutic molecules. Additionally, by showcasing a workflow for a generality- oriented, data science-driven approach to reaction development, this work could inform future approaches to establish more general reactions.